Circuit structure of cognitive maps in the hippocampus

Project Summary
Hippocampus is important for spatial memory. The prototypical neurophysiology is place cells一neurons that
are active at particular places in the environment (place fields). Collectively, place cells are thought to form
cognitive maps, an internal representation of the environment (i.e. spatial memory). Mechanistic models have
made predictions about the pattern of neural connectivity underlying cognitive maps. However, experimental
data of circuit structures are difficult to obtain, because neuronal arbors with synapses at nanometer scale are
densely packed in neuropils that span a millimeter or more in extent even for local circuits. Volume electron
microscopy is currently the only approach that can densely map neural connectivity at synaptic resolution
(connectomics). I have been trained in high-throughput transmission electron microscopy (TEM) techniques in
PhD, and more recently, I have developed an imaging pipeline with four current fastest TEMs. I will use
serial-section TEM imaging followed by circuit reconstruction to map local connectivity in hippocampus.
Furthermore, I will combine two-photon calcium imaging of neural activity during spatial navigation and EM
reconstruction on the same neurons (functional connectomics), to relate place fields of neurons to the
underlying neural circuits in the hippocampus. The goal is to experimentally test long-standing predictions on
patterns of neural connectivity by theoretical models: place cells with neighboring place fields are preferentially
connected with each other. Towards these goals, in my postdoctoral training I will develop methods to register
functionally imaged cells to the same cells in EM-reconstructed volume in the hippocampus and be exposed to
deep learning EM reconstruction approach. The training will take place in Princeton Neuroscience Institute,
under the guidance of Drs. David Tank and Sebastian Seung. With these skills, my goal is to develop an
independent research program of applying functional connectomic methods to relate circuit structure and
function in the hippocampus.

Public health relevance
Project Narrative Hippocampus is an important brain region for learning and memory, and is frequently impacted in common neurological diseases such as Alzheimer's disease and epilepsy, causing memory impairments. In this project, I propose to use state-of-the-art large-scale electron microscopy imaging techniques followed by reconstruction to map the connectivity between cells in the hippocampus. The results can provide important insights into the neural mechanism of learning and memory in the hippocampus.